RNAi-mediated silencing methods for Xenopsylla cheopis, a primary vector forplague transmission.

PROJECT SUMMARY
Fleas are obligate blood-feeding arthropods that are associated with several notable bacterial-derived human
diseases, i.e., rickettsioses, bartonelloses, and plague. Plague caused by the Gram negative bacterium, Yersinia
pestis, is difficult to eradicate because flea-borne transmission is endemic in natural foci of wild rodents and their
associated fleas world-wide. Insecticide control is the primary strategy for disease management, but like many
vector-borne diseases this is compromised by development of insecticide resistance in fleas. Development of
novel vector-based strategies for bacterial pathogen control are therefore a priority. However, to accomplish this,
we must overcome lack of knowledge regarding flea biology, particularly the detailed processes of the flea host
response to infection. But genetic tools enabling such research into this knowledge gap are absent.
Towards this goal and to enable previously inaccessible, yet essential, mechanistic research into
understanding the transmission biology of flea borne plague in future studies, this proposal aims to develop
RNAi-mediated gene silencing methods for Xenopsylla cheopis, a primary flea vector of plague. The biggest
hurdle to effective RNAi-mediated silencing in any arthropod is achieving delivery of exogenous double-stranded
(ds) RNA into the cell cytoplasm to induce specific gene silencing by targeting homologous mRNAs. No one
effective delivery method is currently broadly applicable to all arthropods, requiring that methods be tested and
optimized. Having identified X. cheopis gene target/s in the IMD immune signaling response are specifically
implicated in response to Y. pestis infection, appropriate gene targets are now available to which RNAi strategies
can be developed and tested. Our preliminary experiments demonstrate significant silencing of the IMD gene by
electroporation and microinjection methods of dsRNA delivery. Therefore, in Aim 1 we will determine the most
feasible dsRNA delivery method that enables a high degree of and sustained gene suppression in flea gut-
specific tissue (the site of a Y. pestis infection), as well as low mortality in fleas. In Aim 2 we will use the most
effective method identified to determine if IMD pathway silencing modulates Y. pestis infection rates and burdens
in fleas. The proposed development of a genetic tool to expand research into flea borne plague lies within a part
of the NIH’s mission to develop fundamental knowledge that will assist in reducing the burden of infectious
diseases on human health.

Public health relevance
PROJECT NARRATIVE The proposed exploratory study falls within an important area of plague research. It has potential to develop experimental methodology that is critical to enable, previously impossible, yet essential, mechanistic research into understanding the transmission biology of flea borne plague. These studies will advance fundamental knowledge applicable to decreasing the public health burden of plague and other flea-borne diseases like rickettsioses and bartonelloses.